Emory Health Services Research Center Training Grant

Project Summary
This is an application for the Emory Health Services Research Center Training Grant for postdoctoral trainees (MD
and PhD) at Emory University. The goal of this program is to train diverse candidates in the study of health
services research and health inequities, based on factors such as race/ethnicity, sex/gender, socioeconomic
status, geographical residence, healthcare access, and physical/mental disability, with a focus on the
underlying systemic, behavioral, and environmental mechanisms. A distinguishing feature of our program is the
utilization of a multidisciplinary approach to expose trainees to multiple methods and research areas, from
epidemiology and biostatistics to behavioral and social sciences, biological sciences, and health policy and
implementation. Each trainee has a primary mentor but works within a mentoring team with diverse expertise.
A maximum of 4 postdoctoral trainees will be in the program at any time point, each supported for 2 years.
Training will include multidisciplinary mentoring along with coursework, inter-departmental seminars, hands-on
research, grant writing and career development. Our main source of postdoctoral applicants will be split
between MD and PhD fellows. Postdoctoral fellows will be MDs pursuing a research career in health services,
or PhD graduates in epidemiology, health policy, health economics, or other relevant areas. Post-doctoral
trainees will have the opportunity to obtain an MS in Clinical Research or a Certificate in Clinical and
Translational Research and can select a personalized training pathway with didactic coursework,
supplemented with online trainings from the Institute for Healthcare Improvement and other health system-
engaged experiences. The program will concentrate on successful training and career development, promoted
by solid collaborations among the Rollins School of Public Health, the School of Medicine, and the School of
Nursing. We will strive to appoint fellows from racial/ethnic minority groups and other underrepresented
groups. Our program responds to several emphasis areas for the AHRQ T32 program, including
multidisciplinary training, collaborative research, diversity of trainees, data sciences, translation research,
presentation skills, and project management, with strong emphasis on mentorship and career development.
Addressing health services inequities is a top priority of the strategic vision of the AHRQ. The ultimate goal of
this program is to prepare diverse individuals for leadership positions in health services research in order to
reduce inequalities in health care and health care systems.

Public health relevance
Project Narrative Inequities in access and outcomes of health services are a pervasive problem that has remained essentially unchanged over the past several decades in the United States, particularly in the Southeastern United States. This T32 post-doctoral fellow application proposes to train the next generation of health services researchers to receive multidisciplinary training in methods to both describe and address inequities in access to care, outcomes of care, and healthcare delivery in order to reduce health inequities in health services.